Effect of Neprilysin Inhibition on Myocardial Interstitial Fibrosis

PROJECT SUMMARY / ABSTRACT
Heart failure with preserved ejection fraction (HFpEF) affects 2.5 million Americans and is associated with high
morbidity and mortality. Few effective treatments are available. This proposal will investigate an important cause
of HFpEF: myocardial interstitial fibrosis (MIF). Hypertension, diabetes, and systemic inflammation lead to MIF
by activating fibroblasts, which secrete regulatory proteins that deposit, process, and cross link collagen fibers
in the myocardial extracellular matrix. Treatment of MIF is a potential strategy to prevent or treat HFpEF, but will
require scalable diagnostic tests and proven anti-fibrotic therapies.
Dr. Cunningham, a heart failure cardiologist and early career investigator at Brigham and Women’s Hospital in
Boston, proposes to study MIF using cardiac MRI, large-scale proteomics, and clinical trial methods. Preliminary
data show that inhibition of neprilysin (an enzyme which degrades natriuretic peptides) by the heart failure drug
sacubitril/valsartan reduces plasma levels of several extracellular matrix regulatory proteins. These results
suggest that neprilysin inhibition may attenuate MIF. However, it remains unknown 1) whether plasma levels of
extracellular matrix regulatory proteins are associated with MIF, 2) which extracellular matrix regulatory proteins
are modified by neprilysin inhibition, and 3) whether neprilysin inhibition reduces or slows progression of MIF.
In this proposal, Dr. Cunningham hypothesizes that plasma levels of extracellular matrix regulatory proteins
identify MIF and that neprilysin inhibition reduces MIF through its effect on these proteins. In Aim 1, he will
evaluate whether plasma levels of pre-specified extracellular matrix regulatory proteins are associated with MIF
measured by cardiac MRI in community participants from the UK Biobank. In Aim 2, he will investigate the effect
of neprilysin inhibition on plasma levels of these proteins in a previously conducted HFpEF randomized trial. In
Aim 3, he will conduct a pilot randomized trial directly assessing the effect of neprilysin inhibition on the most
reproducible marker of MIF, extracellular volume measured by contrast cardiac MRI. If successful, these studies
will form the foundation for future R01 applications identifying patients with MIF using proteomics and cardiac
imaging and evaluating the benefit of neprilysin inhibition or other anti-fibrotic therapies in these patients.
These specific aims are part of a comprehensive career development program designed to provide Dr.
Cunningham with the skills to become an independent R01-funded physician-scientist. Dr. Scott Solomon, an
expert in heart failure clinical trials at Brigham and Women’s Hospital, and Dr. Patrick Ellinor, an expert in
cardiovascular epidemiology at the Broad Institute, will mentor Dr. Cunningham. Dr. Cunningham will develop
expertise in the biostatistical analysis of large-scale physiological data, the interpretation of cardiac MRI, and the
execution of heart failure clinical trials. Dr. Cunningham’s long-term goal is to lead clinical trials that leverage
physiological data to precisely target therapies to individual heart failure patients.

Public health relevance
PROJECT NARRATIVE Heart failure with preserved ejection fraction (HFpEF) affects 2.5 million Americans, is rising in prevalence, and is associated with substantial morbidity and mortality. Myocardial interstitial fibrosis contributes to HFpEF, but few tools are available to diagnose or treat it. This proposal will investigate blood markers for diagnosis of myocardial fibrosis, and whether an approved heart failure drug, sacubitril/valsartan, reduces myocardial fibrosis.